Cancer Center Support Grant (CCSG)

PROJECT SUMMARY/ABSTRACT
The mission of the St. Jude Comprehensive Cancer Center (SJCCC) at St. Jude Children's Research Hospital
(SJCRH) is to advance research and cures for pediatric cancer, the leading cause of disease-related death in
children aged 1 to 14 years. For more than 4 decades, we have pursued this mission with the support of a Cancer
Center Support Grant from the National Cancer Institute (NCI). We remain the only NCI-designated Cancer
Center that is dedicated solely to the research and treatment of pediatric malignancies. As such, we serve as a
national and international resource for health care providers, children with cancer, and their families. Through
the support of the American Lebanese and Syrian Associated Charities (ALSAC), a separate organization whose
sole purpose is to raise money in support of St. Jude Children's Research Hospital (SJCRH), we receive robust
institutional support. A total of 75% percent of institutional space and annual budget are invested in the SJCCC.
We propose 5 multidisciplinary research Programs that are organized with the specific intent of translating basic
science discoveries into curative therapies for children with cancer, while minimizing long-term side effects: our
Cancer Biology Program (CBP), which embeds basic cancer research within the heart of the SJCCC, facilitating
direct interaction with the disease-oriented Programs and the major laboratory resources in the Center; our 3
disease-oriented Programs, focused on innovative translational and clinical research in Developmental Biology
and Solid Tumors (DBSTP), Hematological Malignancies (HMP), and Neurobiology and Brain Tumors (NBTP);
and our Cancer Control and Survivorship Program (CCSP), which strives to translate discoveries into effective
strategies to avert or mitigate treatment-related complications and improve the quality of life for survivors of
pediatric cancer. Research by our 114 members is supported by 9 Shared Resources, 1 developing Shared
Resource, and an extraordinary clinical research infrastructure. During the previous funding period, a new
Director was recruited and a new 8-goal strategic plan was launched for the SJCCC. A total of 32,522 clinical
trial enrollments occurred at the Center during the current funding period, of which 60% were to SJCCC
investigator-initiated studies. External peer-reviewed trials, many which are SJCCC member-led, accounted for
another 38% of enrollments. In the last 12 months we were supported by $34.3 million (direct cost) in extramural
funding ($30.3.5 million peer-reviewed; $3.9 million non–peer-reviewed). Since the prior renewal, SJCCC
members published more than 2,100 manuscripts, which includes a marked increase in publications in the
highest-level journals. Our campus has grown in size by 23% and SJCRH and ALSAC have committed to more
than $150 million in new investment to support the SJCCC strategic plan. Despite strategically reducing our
membership by 27% to more tightly focus on cancer research and our strategic plan, NCI funding has increased
by 9.3%, other NIH funding by 9.5%, and our other peer-reviewed funding has increased by 34%.

Public health relevance
PROJECT NARRATIVE The five multidisciplinary research Programs and nine Shared Resources in the SJCCC work together to find cures for pediatric cancer, while minimizing the long-term side effects of treatment. With strong institutional and philanthropic support, for 56 years we have served as a national and international resource for health care providers, children with cancer, and their families.